Investigating the role of astrocyte specific NFIA during initiation and progression of AD pathogenesis

Project Summary / Abstract
Astrocytes are the most abundant and diverse glial cells in the adult brain, comprising 70% of the glial
constituency. Astrocytes perform essential tasks for normal brain function and contribute to various neurological
disorders, including neurodegenerative diseases such as Alzheimer's disease (AD). However, their role in health
and disease remains a mystery. Recently, we found that NFIA contributes to astrocyte-mediated regulation of
brain circuits and memory in the brain, and it was highly increased in reactive astrocytes in the AD mouse brain.
Although the reactive astrocytes are closely associated with degenerating neurons across multiple brain regions
in patients with AD, it is largely unknown how astrocytes contribute to the initiation and progression of AD and
how astrocytic NFIA regulates functions of astrocytes and reactive astrocytes.
Here, using a newly generated animal model, in preliminary data, we found that gain or- / loss of- NFIA
in astrocytes showed decreasing/increasing of A accumulation in AD mouse brain. These results lead us to the
hypothesis that astrocytic NFIA has a role in astrocytes and reactive astrocytes for AD pathogenesis. To test
this, we proposed experiments to confirm NFIA expression in the human AD brain and to analyze AD
pathogenesis in AD mouse brain with behavioral alteration by time different NFIA manipulation in astrocytes
(Aim 1). We next asked how NFIA contributes to the alteration of astrocyte function for AD pathogenesis since
NFIA regulates astrocyte core properties. To test this, we proposed experiments to confirm alteration of A
production / clearance ability of astrocytes, astrocytes calcium activation and astrocyte mediated
neurotransmission by time different NFIA manipulation (Aim 2). Preliminary data revealed that NFIA regulated
AD-related genes in hippocampal astrocytes. Therefore, we will use RNA-seq and ChIP-seq to investigate the
NFIA-regulated candidates and networks for AD pathogenesis in astrocytes and reactive astrocytes.
Furthermore, we will validate the candidates using gene manipulating methods in astrocytes and reactive
astrocytes from the initiation to progression stages of AD pathogenesis (Aim 3).
These results will reveal whether and how astrocytic NFIA contributes to AD pathogenesis and how
astrocytes contribute to AD pathogenesis from initiation to progression. For my career development, these
studies will provide training in the glia-AD relationship under my mentor Dr. Deneen (expert in astrocyte biology)
and co-mentor Dr. Jankowsky (expert in Alzheimer's disease) at Baylor College of Medicine. Since astrocytes
are intimately connected with neurons and are dysregulated in all neurological disorders, this proposal aims to
uncover how astrocytes contribute to neurodegenerative disease development. Towards this goal, the proposed
research will apply new approaches to astrocyte biology to delineate genetic and functional mechanisms involved
in the progression of neurodegeneration.

Public health relevance
Project Narrative NFIA is a critical transcription factor for glial development, astrocyte-neuron network, and astrocyte activation after brain injury. The proposed research will define whether and how the manipulation of astrocytic NFIA is critical for the initiation and progression of Alzheimer's disease through delineating functional relationships between astrocytic genes, cellular signaling, transcriptome analysis, and behaviors of the newly generated AD models. Furthermore, these studies will enhance our knowledge of astrocytic and/or reactive astrocytic mechanisms that may be dysregulated in AD pathogenesis.